Symptoms of Lower Urinary Tract Dysfunction Research Network (LURN) Second Phase Study

NCE Abstract
The administrative supplement will be used to support the successful and orderly closeout of all LURN II study
activities.

Public health relevance
NCE Narrative The administrative supplement will be used to support the successful and orderly closeout of all LURN II study activities.